IMAGING ORGAN FUNCTION IN SMALL ANIMALS

Following successful demonstration of a prototypical analog scintigraphic planar and SPECT imaging system in the previous reporting year(s), efforts were directed towards conversion of this system to fully digital form and to the use of this system for small animal imaging. Corrections for large spatial variations in system gain and non-linearities in spatial positioning were successfully implemented in lookup table format. Additional software was also created, installed and tested to permit system operation in a variety of modes, including sinogram creation for single and multi-slice PET imaging. Hardware was fabricated and/or procured during the reporting period in order to assemble a second detector pair. The second pair will be devoted to developing the PET imaging capability while the first pair is being actively used for small animal imaging. During this reporting period, the system was used to image cerebral blood flow changes in rats in response to sensory stimulation and to visualize and quantify the biodistribution of a new kidney imaging agent.